Investigating obesity-induced altered ovarian intracellular signaling

Abstract: The research proposed is on Health Effects of climate change, specifically related to female
reproductive and general health, in lean and obese females. Since obesity affects ~40% of women, and
disproportionately impacts minority girls and women, this proposal is relevant to the Health Equity aspects of the
climate change and health initiative. This work addresses \ the identified relevant areas of understanding the
effects of climate-change-induced stress on reproduction and development and assesses multiple chemical
(DMBA) and non-chemical stressors (obesity and heat stress) across the lifespan. Climate change and
accompanying frequency of severe HS events is unabating, thus, understanding impacts of HS on ovarian
function is desperately needed. Dr. Keating is uniquely positioned for this study due to her scientific record in
this area of ovarian biology (twenty publications on heat stress biology with the majority related to
reproduction) and the technical feasibility to conduct these studies. The hypothesis is that heat stress will cause
hyperinsulinemia, altering ovarian steroidogenic, DNA repair, oxidative stress and chemical
biotransformation protein abundance, accelerating ovarian toxicity during DMBA exposure, and this will
be heightened in obese relative to lean mice. This hypothesis is based upon our strong preliminary data in
female pig biomedical models and the relevance to the metabolic changes observed during obesity. This
supplement will generate data to pave the way for future exploration into the additive impact of heat stress on
ovotoxicity using tractable mouse models to delve into specific pathways.

Public health relevance
Project Narrative: Understanding ovarian cellular signaling changes that are induced by obesity is critical to improve female fertility and to minimize risk from alkylating chemical exposures. These tools are critical for maintenance and improvement of reproductive health in girls and women.